INTERACTIVE PROGRAM FOR EFFECTIVE PLAYGROUND SUPERVISION

Although more than 200,000 children are treated annually in hospital emergency rooms for injuries incurred on the playground, our review of current teacher training materials reveals no interactive multimedia program targeting effective playground supervision. This project will develop a comprehensive set of multimedia materials to guide elementary school faculty in implementing a school-wide approach to positive and well-disciplined playground supervision. The Phase I prototype will teach playground supervisors effective behavior management techniques. PROPOSED COMMERCIAL APPLICATION: Multimedia educational software is a growing field, with schools comprising a large customer base. The individualization afforded by multimedia, combined with superior instructions design and remediation as needed, make this product a simple cost-effective way for schools to design and implement safe playground policies.